The role of extracellular matrix in estradiol regulation of hippocampal memory consolidation

PROJECT SUMMARY Memory impairment is a defining characteristic of many neuropsychiatric disorders, however our understanding of the neurobiological mechanisms of memory dysfunction and ability to therapeutically address these symptoms remain inadequate. The sex steroid hormone 17β-estradiol (E2) is a powerful regulator of learning and memory and has profound effects in the hippocampus, a region critical to memory formation. E2-induced signaling within the hippocampus is necessary for memory consolidation, but the molecular mechanisms producing this effect are still not fully defined. Therefore, the long-term goal of our research is to determine the molecular mechanisms through which E2 regulates hippocampal memory formation. The overall objective of this application is to determine the extent to which the ECM molecules MMP-9 and β1-integrin are necessary for E2 to enhance hippocampal memory in both male and female mice. Based on previous data showing that MMP-9 and β1-integrin work together as critical regulators of hippocampal plasticity, our central hypothesis is that E2 enhances hippocampal memory consolidation through modification of the ECM via increased MMP-9 enzymatic activity and subsequent activation of cell-surface β1-integrin receptors. The rationale for this work is that by uncovering novel mechanisms of E2 action in regulating hippocampal plasticity and memory, we will improve our understanding, and ability to therapeutically target, estrogenic regulation of hippocampal dysfunction. Our central hypothesis will be tested in two specific aims: 1) determine the extent to which estrogenic regulation of MMP-9 contributes to hippocampal memory enhancement, and 2) determine the extent to which estradiol and β1-integrin receptors interact to produce hippocampal memory enhancement. Both aims will use a combination of biochemical and behavioral methods to characterize the mechanisms and outcomes of E2 regulation of the hippocampal ECM. First, E2 will be directly infused into the dorsal hippocampus of male and female mice and the effects on MMP-9 or β1-integrin expression and activity will be assessed. Then, using one-trial learning tasks and intracranial infusion of pharmacological inhibitors, we will determine the extent to which MMP-9 and β1-integrin influence estrogenic regulation of memory consolidation. This work is innovative in that it represents a fundamental shift from the conventional focus on intracellular signaling mechanisms to consider the potentially important contribution of the ECM in estrogenic regulation of memory consolidation. By directly assessing the contributions of the ECM to estrogenic memory regulation, we will advance the existing model of E2 signaling in the hippocampus to integrate extracellular and intracellular signaling processes. This contribution is significant because it will provide essential foundational knowledge about the mechanisms through which estradiol regulates memory formation in the male and female brain, which will serve to generate new putative therapeutic targets for memory dysfunction.

Public health relevance
PROJECT NARRATIVE Memory impairments are characteristic of many neurodevelopmental and neuropsychiatric disorders, yet the development of effective treatments to reduce these impairments is hampered by our rudimentary knowledge about the neural mechanisms through which memories are formed. The proposed research is relevant to public health because it will fundamentally advance our understanding of the neural mechanisms underlying memory formation, which will provide sorely needed insights that could lead to the generation of novel therapies specifically tailored to reduce memory dysfunction. Thus, the proposed research is particularly relevant to the NIMH’s first Strategic Objective of promoting discovery in the brain and behavioral sciences to fuel research on the causes of, and treatments for, mental disorders, and specifically addresses strategy 1.1 which seeks to develop an integrative understanding of basic brain-behavior processes that provide the foundation for understanding mental disorders.